Chemically Modified Peptide Nucleic Acids

Our research on Peptide Nucleic Acids (abbreviated as PNAs) focuses on introducing chemical modifications that will make this class of molecules broadly useful to detect sequences of DNA and to suppress the progression of specific diseases. Unique DNA sequences are associated with diseases, pathogens, and many agents associated with bioterrorism. Detection of DNA from these agents can be employed as a method to detect their presence or absence. Our research involves the synthesis of a class of non-natural molecules (called PNAs) that bind to specific DNA sequences. We can design our molecules to bind to any sequence of DNA, and previously we have found that our molecules are extremely good at selective recognition of DNA associated with anthrax. During the past year, we have improved the chemistry to make our molecules, and have continued to refine our assay using our PNA molecules to detect anthrax DNA. We are currently looking to extend our detection system to the H1N1 (swine) flu. PNAs are also useful as antisense and antigene molecules, however delivery into cells has been difficult. We are starting a collaboration looking for specific delivery agents based on known bacterial proteins that help transport cargo into cells. Finally, we are exploring the potential of other PNAs as basic scaffolds for nanotechnology. Using a system of long DNA sequences, we are developing conditions for the self-assembly of specific PNAs onto DNA strands as a way to create nanopatters of specific biological ligands.